DECIPHERING MECHANISMS OF IL-37 MEDIATED CONTROL OF PERIODONTAL INFLAMMATION

ABSTRACT
This K08 application is to support the research and career development of Dr. Adam Lietzan, a periodontist and
research assistant professor at the UNC Adams School of Dentistry. This award will provide Dr. Lietzan an
intensive mentored experience in order for him to complete the transition to an independent clinician-scientist
with a research program focused on understanding the dynamic immune responses to microbial dysbiosis during
periodontitis. As such, a training plan including didactic, hands-on, and career development experiences has
been put forth to enable this transition. During this award, Dr. Lietzan will gain skills/knowledge in: 1) host-
pathogen interactions, 2) cutting-edge techniques to evaluate immunological responses, 3) proposal
development, scientific writing, and oral presentations, and 4) leadership. This will allow Dr. Lietzan to develop
collaborative opportunities with scientists and clinicians across multiple disciplines and a high-quality
independent research program. Dr. Lietzan has established a multi-disciplinary team to provide expertise in
research training and mentorship in career development. Together this team will provide foundational training in
immunology, cell-based techniques, and animal models as well as help advise with critical aspects of the career
development. This will be coupled with a strong research plan. The onset of inflammation is facilitated by a
cascade of signaling molecules released by both canonical (e.g. macrophages) and noncanonical immune cells
(e.g. epithelial cells). The highly potent interleukin (IL)-1 family of signaling molecules primarily induces
inflammatory damage and is heavily implicated in periodontitis development and severity. Interleukin-37, an IL-
1 family member, conversely suppresses inflammation and has been shown to be dysregulated in severe forms
of periodontitis. The oral epithelial cell (OEC), which acts as a physical, chemical, and immunological shield
against infection, highly expresses IL-37 when exposed to microbial stimuli. Despite this knowledge, the impact
of IL-37 on OECs and the molecular interactions that underlie its anti-inflammatory bioactivity in periodontitis
remains largely uncharacterized. Here Dr. Lietzan seeks to fill this knowledge gap by dissecting the cellular
pathways that IL-37 modulates during microbial challenge of OECs using in vitro and in vivo model systems. The
molecular interactions between IL-37 and its receptors, which are highly expressed on OEC, will also be
delineated. Lastly, the relevance of glycosaminoglycans (GAGs) within the periodontal extracellular matrix on IL-
37 bioactivity will be investigated. Successful completion of this proposal will inform the development of new
and/or improve existing IL-37-centric interventions aimed at modulating chronic inflammation, such as that
associated with periodontitis. Together these training and research activities will be a significant step towards
Dr. Lietzan achieving his long-term goal of becoming an independent clinician-scientist who can bridge the gap
between basic science discovery and clinical care advances through a multi-disciplinary approach.

Public health relevance
PROJECT NARRATIVE The onset of periodontitis involves an influx of immune cells and a cascade of inflammatory biomolecules in response to a dysbiotic microbiota. Interleukin-37, an anti-inflammatory cytokine, is dysregulated in severe forms of periodontitis; however, its role in the disease’s pathogenesis remains poorly defined. The proposed research will begin to unravel the complex processes that interleukin-37 employs during periodontal inflammation with emphasis on regulatory mechanisms required for its bioactivity in the innate immune response by the periodontium.